IGF::CL::IGF: This service is for Meeting Planning and Administration.

The 20th Annual Udall Center Meeting will be held on October 16-17, 2018 at 5701 Marinelli Road, Bethesda, MD 20852. POP: July 02, 2018 - January 7, 2019